Regulation of endothelial cell invasion, migration and cell junction plasticity

Project Summary
One of the main research directions of my laboratory focuses on regulation of the endothelial barrier and
endothelial cell migration. These processes are critical for physiological function of vascular system and they
are often dysregulated in human diseases. A lot of progress has been made in understanding signaling that
regulates endothelial barrier and cell migration. However, stimulation of endothelial cell migration during
angiogenesis is a highly localized and transient event. Defining the role of the local and temporal components
of angiogenic signaling has been challenging due to limitations of current tools. Furthermore, spatiotemporal
regulation of the endothelial barrier by these stimuli has been poorly understood. Our proposed work will focus
on determining how the location and duration of migratory signals direct endothelial cell invasion and migration
through extracellular matrix, and how they affect the organization and permeability of the endothelial barrier.
The endothelial barrier is controlled at the level of adherens junctions (AJs), cell-cell adhesion structures
mediated by the transmembrane protein VE-cadherin. Phosphorylation-mediated signaling regulates the
structure and permeability of AJs. In our recent studies, we described a dual role of tyrosine kinase Src and its
phosphorylation of VE-cadherin in regulation of endothelial permeability. Our results demonstrated that Src-
mediated phosphorylation induces formation of dynamic AJs that still retain their barrier function. This suggests
a mechanism for the regulation of AJ plasticity that does not compromise barrier permeability during
endothelial cell migration. In parallel studies, we dissected a mechanism of Src-regulated degradation of the
extracellular matrix by the endothelial cell and discovered a novel cytoskeletal component that mediates
formation of matrix-degrading podosomes. The studies proposed here will continue to build on our previous
findings and focus on dissecting how phosphorylation of VE-cadherin and angiogenic signaling by Vascular
Growth Factor Receptor 2 (VEGFR2), Sphingosine-1-phosphate Receptor 1 (S1PR1), and Src regulate
plasticity of AJs as well as invasion and migration of endothelial cells. We will employ novel optogenetic tools
that will allow us to interrogate these processes with precise spatial and temporal control. We will use
engineered light-regulated VEGFR2, S1PR1, and Src to determine the effects of locally and temporally
controlled angiogenic signals and dissect mechanisms that mediate regulation of AJs and migration of
endothelial cells in three dimensional environment. Our long-term goal is to define the processes that control
migration of endothelial cells and endothelial barrier function during angiogenesis.

Public health relevance
Project Narrative Endothelial cell migration and cell-cell interactions are fundamental processes mediating physiological angiogenesis and they are often dysregulated in human diseases. The proposed project will define how these processes regulated in time and space and identify components of this regulation. The proposed studies will reveal important factors regulating angiogenesis and guide future development of potential therapeutic strategies.